Preclinical Development of a Therapeutic Antibody for Type-1 Diabetes

Abstract
Type 1 diabetes (T1D) is a chronic autoimmune disease that affects approximately 1.5 million Americans, with
an estimated economic impact nearing $1 trillion. The disease progresses through three stages: it begins with
the presence of autoantibodies and normal blood sugar levels (stage 1), advances to dysglycemia without clinical
symptoms (stage 2), and culminates in clinical diabetes (stage 3), where insulin therapy becomes mandatory to
manage blood sugar levels and prevent complications. If left untreated, T1D can lead to life-threatening
ketoacidosis, while insulin overdose may cause severe hypoglycemia, potentially resulting in loss of
consciousness or death if not promptly addressed. Despite advancements in T1D treatment, many patients
struggle to meet treatment goals, increasing their risk of long-term complications like cardiovascular disease,
kidney damage, nerve damage, and vision impairment. T1D is caused by the autoimmune destruction of insulin-
producing beta cells within the pancreatic islets. There is an urgent clinical need for therapies that can
simultaneously reverse autoimmunity and restore beta cell function and mass. Currently, Teplizumab, an anti-
CD3 monoclonal antibody, is the only approved immunotherapy to delay the onset of clinical T1D in stage 2
patients. However, concerns about broad immune suppression limit its use as a chronic treatment to permanently
halt progression from stage 2 to stage 3 T1D. A durable and restorative therapy for T1D remains an unmet need.
Islex Therapeutics aims to develop a first-in-class, islet-targeted antibody therapeutic to address this gap. We
have identified a novel islet-homing antibody therapy that has demonstrated complete protection and reversal of
new-onset T1D in mice without adverse effects during long-term monitoring. The objective of this phase I SBIR
application is to establish proof-of-principle for a humanized therapeutic lead by validating its islet-homing
capability (Aim 1), its therapeutic efficacy in reversing new-onset diabetes in a mouse model of T1D (Aim 2), and
its ability to protect human islets against human T-cell cytotoxicity (Aim 3). The proposed Phase I study will lay
the groundwork for Phase II development, focusing on preclinical toxicology studies and antibody drug product
manufacturing, ultimately leading to clinical trials in patients with stage 2 and new-onset stage 3 T1D.

Public health relevance
Project Narrative This project aims to develop a precision antibody therapeutic for type 1 diabetes. Through this phase I SBIR application, our objective is to validate target engagement and therapeutic efficacy, thereby laying the groundwork for clinical trials in patients with stage 2 and new-onset stage 3 type 1 diabetes.